LAMPS

PROJECT SUMMARY- CORE 3
Condensates formed by macromolecular assemblies play a crucial role in chromatin regulation; however, the
fundamental principles governing how functional partners interact within condensates to regulate gene
expression remain elusive. A key limiting step is the lack of experimental means for the inducible formation and
purification of condensates from native chromatin in disease-relevant cells. Due to this limitation, it remains
unclear whether the formation of nuclear condensates is the causal mechanism of fusion oncoprotein (FO)-
mediated gene activation or simply the consequence of activated gene expression. The Advanced Technology
and Genomics (ATG) core at St. Jude Children’s Research Hospital serves as Core 3 for the FusOnc Program
Project by providing new technology platforms, namely Light-Activated Macromolecular
Phase Separation (LAMPS), for studying the causal relationships between FO-mediated condensate
formation, chromatin dysregulation, and oncogenic gene transcription in multiple pediatric cancers. LAMPS
incorporates CRISPR-based chromatin purification, optogenetics, and multi-omic approaches to 1) determine
whether and how FO-mediated condensation reprograms chromatin regulation, 2) identify the
macromolecular components of FO condensates in native chromatin, and 3) elucidate the mechanism(s) of
condensate-mediated chromatin dysregulation for oncogenic function. Leveraging the extensive expertise
of the ATG core in innovating technologies for studying genome regulation (see later in this section and
biosketches), Core 3 will provide technical support, consultation, and services to all Projects for the
application of LAMPS to a diverse set of FOs, including study design, experimentation, and statistically
rigorous analysis and interpretation of multi-omics datasets. Together with other project leaders, our Core
team has the potential to capitalize on the collective expertise and interdisciplinary approaches,
producing novel insights into understanding the molecular underpinnings of FO-mediated oncogenic
functions.

Public health relevance
PROJECT NARRATIVE - CORE 3 Core 3 will provide new technology platforms by incorporating CRISPR-based chromatin purification, optogenetics, and multi-omic approaches to dissect the relationships between fusion oncoprotein-mediated condensate formation, chromatin dysregulation, and oncogenic gene transcription in multiple pediatric cancers. All Projects will be supported by this Core.